Administrative Core

Abstract
The overall objectives of Core A (Administrative) are to provide administrative services to all Projects and Cores
to ensure programmatic, effective, efficient, and collaborative interactions of the PPG team. The PPG
administration will operate in the University of Nevada, Reno's School of Medicine, within the Department of
Physiology and Cell Biology's general administrative structure. The Specific Aims of the Core are Aim 1. To
provide administrative services (financial management, organization, oversight, human resources, dissemination
of information, outreach, and clerical support) to all Projects and Cores. Aim 2. To coordinate the PPG team's
programmatic, effective, efficient, and collaborative interactions, including External, Internal, and Scientific
Advisory Committees. The Core will maintain and organize daily-to-weekly blogs, monthly video-conferencing,
and journal clubs, as well as Annual Retreat and Midwinter meetings. Aim 3. To administer contractual
agreements with the Ohio State University (OSU), the University of Pittsburgh (UPitt), the University of Iowa (UI),
the University of California, San Diego (UCSD), and the Pacific Northwest National Laboratory (PNNL). Aim 4.
To ensure that the overall objectives of the collaborative projects are met on time. Aim 5. To provide oversight
to ensure full compliance with regulatory requirements (Animal Care and Use, Resource Sharing, Public Access
for Publications, Management, Reporting of Finances, and communication with the NIA personnel, through UNR
sponsored office).

Public health relevance
Project Narrative Age-related hearing loss (ARHL), often called presbycusis, is the most common neurosensory deficit in our aging population, but no FDA-approved drugs or therapeutic armamentarium for sensorineural hearing loss (HL) are available. The overall goals of the Administrative Core are to provide administrative services to all Projects and Cores to ensure programmatic, effective, efficient, and collaborative interactions of the investigative team.